SToP Cancer SPORE: Developmental Research Program

DEVELOPMENTAL RESEARCH PROGRAM: ABSTRACT
The Developmental Research Program (DRP) is critical to the UNC SToP Cancer
SPORE mission to advance basic understanding of pancreatic cancer development and
progression, and to develop new therapeutic approaches. The overarching goal of the
SPORE DRP is to identify and provide research support for innovative projects that
provide key insight into critical areas of pancreatic cancer research. Funded DRP
projects should provide compelling evidence of potential to develop into full projects
within the SPORE and/or to be funded by peer-reviewed federal (NIH/NCI, DOD) or
foundation resources. Each year with institutional support, the DRP intends to fund up
to three projects of approximately $100,000, with a second year of funding dependent on
progress in the first year. Budget flexibility will be built in if the senior leadership
determines that a project is particularly promising. RFAs for the UNC SToP Cancer
SPORE developmental projects will be offered once a year, with proposals solicited from
UNC, and our sister institutions which include NC State University and NC Central
University. The DRP Review Committee will review applications focused on pancreatic
cancer basic research (such as cancer cell signaling, cell biology, and genetics);
translational research (biomedical engineering, cancer imaging, cancer
immunology/immunotherapy, and therapeutic approaches); and population research,
including cancer prevention and control.

Public health relevance
DEVELOPMENTAL RESEARCH PROGRAM: PROJECT NARRATIVE The Developmental Research Program of the UNC Pancreatic Cancer SPORE supports developmental research into causes and treatment of pancreatic cancer. Announcements for funding will be widely distributed to all UNC faculty and to partner institutions. Evaluation of projects will be performed by the DRP review committee.